PANCREATIC TRANSPLANTATION AND INSULIN/GLUCOSE HOMEOSTASIS

This protocol has been completed and did not admit patients during this reporting period. It utilized the biostatisticians for analysis and interpretation of data, and preparation of manuscripts. Citations are included in the Publications section.